Computational Modeling Core

Project Summary: Computational Modeling Core
Our team for this BRAIN Initiative U19 proposal on Oxytocin Modulation of Neural Circuit Function and Behavior
is located at NYU Grossman School of Medicine, and staff for the Computational Modeling Core are located in
the NYU Neuroscience Institute alongside the Oxytocin U19 Project and other Core labs. This proximity facilitates
their interactions, which has produced a number of ongoing collaborations and will promote the development,
validation, implementation, standardization, and dissemination of computational analyses of oxytocin function
that are the foundation of this proposed Computational Modeling Core. Core Director Dr. Kenway Louie is a
computational neuroscientist with extensive experience in network modeling and behavioral analysis, who will
lead a team of postdoctoral-level staff with expertise in the proposed modeling techniques.
This Computational Modeling Core will serve as a centralized resource for computational modeling
relevant to oxytocin mechanisms in Project team lab research, coordinating theoretical, analytic, and simulation
approaches across the Project labs. This research support will enable theoretically-motivated collaborations
between the four Project labs, standardize computational modeling approaches to predict behavioral effects of
cellular, synaptic, and circuit changes, provide an integrated, hierarchical modeling framework for different social
behaviors, and provide straightforward and robust access to the computational examination of oxytocin
modulation of circuit function and behavior for all U19 team members. Aim 1 of the Computational Modeling Core
is to develop circuit-based models of oxytocin function and individual animal behavior. Using established
dynamical rate models customized to circuits of interest, this approach will identify specific oxytocin-related
experimental manipulations relevant to the brain areas under study, allowing comparison to experimental data
and hypothesis testing about circuit-specific oxytocin function. Aim 2 is to develop agent-based models (ABM)
of multi-agent social behaviors, which will examine how oxytocin contributes to the relationship between neural
computations, individual animal behavior, and emergent multi-agent social behaviors. This work will make
predictions about the effect of specific manipulations (e.g., oxytocin receptor knockout) on specific behaviors
(e.g., social hierarchy formation), test ABM predictions in empirical behavior, and refine our understanding of the
computational and cognitive role of oxytocin in different social behaviors. Aim 3 is to develop a unified theoretical
framework that synthesizes modeling approaches for diverse datasets, specifically drawing on both the
dynamical modeling of Aim 1 and ABM frameworks of Aim 2, to capture multiple timescales of social behavior.
We will work closely with the Data Science and Behavior Cores to standardize model structures, simulated
behavioral and neural data, and metadata curation. We will also ensure accessibility of our work by maintaining
a dedicated U19 Computational Modeling Core source code repository.